RELATIONSHIP BETWEEN SENSORINEURAL HEARING LOSS &MITOCHONDRIAL DNA MUTATION

This study will determine the frequency of mitochondrial DNA mutation in hearing impaired Special Care Nursery graduates and compare it to the frequency in matched control infants with normal hearing.